Ensuring medication ingestion without altering existing medication regimen

PROJECT SUMMARY
In the US, approximately 835,000 persons are living in assisted living facilities with more than 50 percent
of those having some form of dementia or cognitive impairment. The average cost of those living in assisted
living facilities is $4050 per month, with memory care increasing this cost by an average of $1250 per month.
Advancements in medications such as Donepezil, Galantamine, and Rivastigmine have been shown to help
manage and even reverse some dementia symptoms, but these medications are not effective unless they are
taken on a regular basis. Slowing the progression of dementia can prolong the ability of persons to live
independently. While the use of blister packs and pill boxes are designed to help ensure that patients are taking
medications on a prescribed basis, these technologies report intent to ingest and often do not provide any
feedback that can be monitored by others outside the home. Given that 53 million US citizens are already past
retirement age and that 70 percent will require some form of long-term care in their lifetime, it is clear that the
cost of managing this disease will continue to grow unless alternative solutions are put in place.
In Phase I of the grant we propose to enhance the FDA cleared ID-Cap system by building a home-based
ingestion monitoring system that can detect medication ingestions within the home instead of requiring a user to
wear an ID-Cap Reader. The ID-Cap system is currently designed to detect ingestions by sending out a small
radio signal from within a person's stomach when an ID-Cap is ingested. The existing system detects these
signals using a lanyard-style reader. As these patients may forget to use the reader, we propose to create a
new reader design that can “hear” the ingestion from across the room using improvements in antenna design
and signal processing. To ensure detection if a patient takes their medication in different rooms, a mesh network
of readers placed in the home can ensure that the signal is detected and forwarded to the existing cloud-based
monitoring platform. In Phase I, we propose two specific aims.
Aim 1 – Create a prototype wall-plug based networked reader
Leveraging our experience developing the existing ID-Cap wearable reader, we will design a new generation
reader that will be able to detect ingestions within a room instead of requiring the user to wear a reader. The
captured signals will be forwarded across a mesh network to a base station that ensures delivery to a cloud
repository so that care providers can monitor actual ingestion events and intervene if needed.
Aim 2 – Evaluate effectiveness and acceptability of the new system in 3 simulated environments
Using the prototyped base station and networked readers, we will evaluate the ability to detect signals in three
different home configurations. This feedback will help inform installation configuration designs regarding the
optimal number and placement of readers. Interviews with persons with dementia and their caregivers will inform
acceptability.

Public health relevance
PROJECT NARRATIVE For many of our aging population, remembering to take medication can be difficult. Non-adherence to a prescribed medication regimen is a leading cause of relocation to a costly assisted living facility. A multitude of products have been developed to try to address this issue, including pill boxes and blister packs, but often pills removed from containers are not ingested. In this proposal we build a network of sensors that can be placed throughout the home that capture signals from ingested medications that have been encapsulated in ID-Capsules. This solution forwards the captured ingestion information to a monitoring facility that can intervene when medications are under or over dosed.